Mechanisms of transcriptional control of adipocyte formation and function through nuclear receptor coactivators

PROJECT SUMMARY
Dysregulation of energy storage in white adipocytes and of energy expenditure in brown or beige adipocytes,
respectively, cause lipodystrophy and obesity, which lead to metabolic disorders that include insulin resistance,
diabetes, and cardiovascular disease. A favorable metabolic state is achieved through storage of excess energy
as lipids by white adipose and dissipation of energy as heat by brown adipose, as well as by conversion of white
adipose tissue to brown-like beige tissue. Studies, including our own, have established that adipose tissue
physiology is largely regulated at the level of transcription by a web of interactions between nuclear receptors
(NRs) that include PPARs and ERRs and their associated coactivators, including the multi-subunit Mediator
complex, that are recruited to enhancers of adipocyte-specific genes. Remarkably, our biochemical and genetic
studies in mice collectively demonstrate conditional requirements for the two NR-interacting NR boxes of the
MED1 subunit of the Mediator and consequent dramatic beneficial effects of attenuating NR-Mediator
interactions via the NR boxes. However, the detailed mechanisms underlying these observations remain
completely unknown. We hypothesize that differential recruitment of cofactors by unique combinations of NRs
and other transcription factors bound to target gene enhancers determines their adipocyte-specific
spatiotemporal expression patterns. Our hypothesis further posits that Mediator recruited by these factors is the
critical node in establishing the locus-specific higher-order complexes that ultimately determine the amplitude of
the transcriptional output. Here, we propose a holistic approach that merges biochemical and cell- and animal-
based methods to investigate how adipocyte identity arises from combinatorial effects of enhancer-bound NRs
and other transcription factors as channeled through the Mediator. Our specific aims therefore are (i) to uncover
using in vitro transcription, cross-link mass spectroscopy, multiomics, and rapid degradation approaches how
cooperative interactions of PPARg, C/EBP pioneer factors, Mediator, and other coactivators at adipocyte lineage-
specific enhancers give rise to a transcriptional program that establishes white and brown adipocyte identity, as
well as how additional interactions among ERRg, NCOA3, and Mediator are specifically responsible for function
of brown/beige adipocytes; and (ii) to analyze how transcriptional activation proceeds in mature adipocytes, both
when Mediator recruitment to the enhancer is mediated by MED1 NR boxes and when alternate pathways are
operative. The underlying cellular and molecular mechanisms of the metabolically favorable phenotypes of mice
harboring MED1 NR box mutants under obesogenic conditions will also be investigated. Projected research
outcomes thus include both a detailed understanding of enhancer-mediated transcriptional mechanisms that
regulate the formation, interconversion, and function of different adipocyte cell types, as well as insights into
rationally developing therapeutic modalities for treating metabolic diseases.

Public health relevance
PROJECT NARRATIVE Aberrant transcription of adipocyte-specific genes in white and brown or beige adipocyte tissues causes obesity and lipodystrophy, which lead to metabolic disorders that include insulin resistance, diabetes, and cardiovascular disease. These genes are regulated at the level of transcription by a complex web of physical and functional interactions between nuclear receptors, other transcription factors and transcriptional coactivators. This proposal will reveal new insights into mechanistic and biological aspects of these interactions, thereby opening up novel therapeutic avenues.